Brain-Imaging Markers of Neurotoxicity and Long-Term Outcomes after CAR-T Cell Therapy

Project Summary
CD19-directed chimeric antigen receptor (CAR)-T cell therapy for relapsed or refractory B-cell acute
lymphoblastic leukemia (ALL) induces complete remission in 70-90% of otherwise incurable patients. CAR-T
cell engagement with their target antigens induces expansion of activated CAR-T cells, producing cytokines
and other pro-inflammatory mediators. Unfortunately, in approximately 50% of patients this inflammatory
response also produces an Immune effector Cell-Associated Neurotoxicity Syndrome (ICANS), a serious
neurotoxicity characterized by delirium, encephalopathy, dysphasia, and in severe cases, diffuse cerebral
edema that can be fatal. Additionally, ICANS increases the risk for long-term cognitive impairments; possible
consequences that have not been systematically studied. ICANS therefore remains a major challenge for the
wider adoption of CAR-T cell therapy, creating an urgent need to mitigate or prevent ICANS, to understand its
pathophysiology, and to predict its adverse long-term outcomes. We have compelling preliminary data
demonstrating that several pre-infusion neuroimaging markers predict ICANS with high accuracy. Building
upon these findings, we will develop a predictive algorithm in this proposal that will facilitate closer monitoring
of high-risk patients, support with preventive treatments, and risk-adapted dosing of CAR-T cells. Our
preliminary data also suggest that neuroimaging biomarkers serve as objective surrogates for clinical and
subclinical ICANS. These markers may guide future development of targeted anti-cytokine and small molecule
inhibitor-based interventions to inhibit or block neurotoxicity-specific pathways. Finally, preliminary data support
our hypothesis that ICANS-induced abnormalities in attentional networks of the brain cause long-term
neurocognitive impairments. Adverse outcomes are also seen in low grade neurotoxicity, suggesting a greater
need than previously anticipated for cognitive and behavioral interventions in CAR-T cell patients, rather than
only in patients with florid neurotoxicity. Expanding on our pilot study, we propose to conduct a prospective,
longitudinal cohort study of 80 consecutive patients who receive CAR-T cell therapy for B-ALL. We will collect
state-of-the-art (a) clinical assessments for ICANS and CRS, (b) multi-modal MRI to characterize brain
structure, function, and metabolism, (c) peripheral blood samples for immunophenotyping using CyTOF (mass
Cytometry by Time-Of-Flight) and to profile cytokines and biomarkers of blood brain barrier integrity, and (d)
neurocognitive testing to characterize cognitive changes. Longitudinal data will be collected at (1) a pre-
infusion baseline; and then post-infusion on (2) Day 10, when the ICANS risk is greatest, (3) Day 28, upon
ICANS resolution, and (4) month 12, for long-term outcomes. These data will identify, with unparalleled
inferential capacity, brain-based predictors and inflammatory mediators of ICANS, help develop brain MRI
guidelines for CAR-T cell therapy, and help recommend specific cognitive training and neuroprotective
strategies in patients with persistent brain deficits.

Public health relevance
Project Narrative Children who receive CAR-T cell therapy to cure their leukemia can develop life threatening neurological side effects. We will use neuroimaging and other markers to predict whether a child will develop these severe neurotoxicities and determine whether neurotoxicity-induced brain damage causes long term problems in cognition and behavior. The biomarkers that we will identify will guide future clinical trials of safe and effective treatments to prevent neurotoxicity and interventions to alleviate long term impairments.